POLYAMINE BIOSYNTHESIS AND FUNCTION

The polyamines, putrescine, spermidine, and spermine, are major polybasic compounds in all living cells. These amines have been shown to be important for many systems related to growth and differentiation. We have been interested in how these polyamines are synthesized, how their biosynthesis and degradation are regulated, their physiologic functions, and how they act in vivo. For this purpose we have constructed null mutants in each of the biosynthetic steps in both Escherichia coli and in Saccharomyces cerevisiae. These mutants are unable to make these amines, and hence they are very useful tools to study the physiological effects due to their deprivation. Our present studies are directed at extending our studies on the biochemistry, regulation and genetics of these amines and of the biosynthetic enzymes in S. cerevisiae. Our older work and our current work have demonstrated that the polyamines are required for growth of the organisms, for sporulation, for maintenance of the killer dsRNA virus, for protection against oxidative damage, for protection against elevated temperatures, for fidelity of protein biosynthesis, and for the maintenance of mitochondria. Clones have been constructed that overproduce the various enzymes, and the sequence and structural characteristics of these enzymes have been studied. We have concentrated particularly on this structure and regulation of ornithine decarboxylase, spermidine synthase, and S- adenosylmethionine decarboxylase.